Investigating conserved mechanisms that orchestrate the prophase to metaphase transition during meiosis I

Sexually reproducing organisms generate gametes through meiosis, the process by which the genetic material
of the cell is halved to form a haploid sperm or egg. Although essential for all animal life, meiosis is strikingly
error-prone, with an estimated 5-25% of all human conceptions resulting in an aneuploid embryo, often leading
to severe developmental defects and pregnancy complications that effect millions of individuals every year.
Therefore, it is critical to investigate the core molecular mechanisms that define progression through meiosis to
further understand what checkpoints may exist to sense errors. This proposal investigates the control of
meiotic progression using two powerful meiotic models, the lab mouse Mus musculus and the nematode
Caenorhabditis elegans. Meiosis I proceeds through pairing, synapsis, and crossing over (CO) of homologous
chromosomes during prophase, and only once these events have occurred correctly can homologs align
appropriately on the meiotic spindle and then segregate equally at the first meiotic division. However, it is unclear
how successful CO formation is sensed by cell cycle machinery to progress meiosis into M-phase. Proper CO
formation requires orthologous cyclin-like domain containing proteins CNTD1, in mouse spermatocytes, and
COSA-1, in C. elegans oogenesis. Interestingly, CNTD1 interacts with CDC34, a ubiquitin E2 conjugating
enzyme that acts with the Skp1-Cullin-F-Box (SCF) family of E3 ubiquitin ligases. A known target of CDC34 in
mitotic systems is the cell cycle M-phase inhibitor, WEE1. In CNTD1 knockout mouse spermatocytes, CDC34 is
absent from nuclei and WEE1 persists aberrantly through until the end of meiotic prophase, suggesting a role
for CNTD1-promoted crossover maturation in WEE1 degradation and resulting progression into M-phase. This
leads to the hypothesis that progression from meiotic prophase I to M-phase I is licensed through direct
WEE1 ubiquitination by SCFCDC34 in a crossover-dependent manner that is conserved across eukaryotes.
This proposal presents two specific aims: 1) Is SCFCDC34-mediated ubiquitination of WEE1 critical for progression
from meiotic prophase I to M-phase I? WEE1 ubiquitination and WEE1/CDC34 chromatin localization will be
directly tested in both wild type and crossover deficient mutant mice. An assay will be developed to directly
visualize the germ line abundance of the WEE1 ortholog in C. elegans, WEE-1.3, to test the role of WEE-1.3 in
C. elegans meiotic progression. 2) What is the biochemical mechanism of SCFCDC34 mediated WEE1
ubiquitination? The molecular components of the SCFCDC34 complex will be elucidated in mouse spermatocytes
through mutant analysis of putative complex members, and in C. elegans through a RNAi screen. This work will
be performed in the lab of Dr. Paula Cohen in the Cornell University College of Veterinary Medicine, providing
extensive training in mammalian reproductive biology, specifically in the early meiotic events during
gametogenesis. This research strategy coupled with the applicant’s training and career development plans will
provide a unique approach towards investigation of meiosis through using complementary model organisms.

Public health relevance
PROJECT NARRATIVE Meiosis is the mechanism by which animals produce mature eggs and sperm through halving the amount of genetic information in the cell. Errors in meiotic processes, in particular the physical tethering of maternal and paternal chromosomes before separating them, are strikingly common and often result in severe pregnancy complications or developmental defects. This proposal aims to understand how developing sex cells ensure error-free progression through the perilous events of meiosis.